Consulting services for BPN-Biological Therapeutics Development and associated External Oversight Committee.

The purpose of this requirement is to procure pharmacology consulting services in support of NIH Blueprint Neurotherapeutics Network drug discovery and development programs and the associated BPN External Oversight Committee. The NIH is seeking to procure a highly experienced executive-level, drug discovery and development subject matter expert with experience in the area of Pharmacology to provide feedback to the NIH program leadership and technical guidance on drug discovery and development projects within the BPN portfolio. The Contractor will serve as a member of the BPN External Oversight Committee, which provides strategic guidance on BPN projects and on occasion other NIH drug discovery and development programs.